EVALUATION OF INTRAVENOUS UK-68,798 IN PATIENTS WITH ATRIAL FIBRILLATION

To test the hypothesis that withdrawal of neurohormonal activation following conversion of atrial fibrillation exaggerates the QT prolonging effects of class III antiarrhythmics.